Core C

PROJECT SUMMARY
Understanding sphingolipid metabolism in acute myeloid leukemia (AML) requires holistic approaches that are
suited for the complexity of the disease and the resources available to study it. The Integrative Systems Biology
Core (Core C) supports the overall aims of the program project grant by using large, shared AML datasets to
test project-specific hypotheses. Core C personnel have established track records in data-driven modeling,
bioinformatics, and metabolic networks applied to AML and other cancers. Services of Core C include: 1)
Signature identification and refinement; we will improve existing sphingolipidomic signatures and connect
different types of biomolecular data with drug response data using established statistical approaches. 2) Data
harmonization and inference; we will combine publicly available AML datasets to enable external comparisons
with data from the research projects. 3) Metabolic network modeling; we will develop personalized sample-
specific metabolic models to examine variations and metabolic changes between patient cases and experimental
conditions. Core C complements the conventional biostatistics offered by Core D and will contextualize the
primary data generated by Cores A and B through the specialized AML repositories and models it builds for the
research projects.

Public health relevance
PROJECT NARRATIVE This research core will enable projects to tackle more sophisticated questions by using large datasets in the public domain together with their own results. The core will build models that simplify complex datasets and biological processes, building predictive tools for drug efficacy and mechanism of action. The goal is to accelerate research progress by leveraging existing information to fulfill project goals related to therapeutic development and discovery for acute myeloid leukemia.